CORE--STATISTICS AND DATA MANAGEMENT

1. Biostatistical core. The specific aim of this core is to provide statistical consultation and collaboration with respect to methodology, feasibility, safety monitoring, analysis and reporting of clinical trials and laboratory studies to maximize research efforts within the bone marrow transplantation program. 2. Data management core. The specific aim of this cord is to provide data management in a systematic, efficient and coordinated fashion so that accurate, complete, validated data are available, in a timely fashion, to allow investigators to better assess, analyze and report research efforts and more effectively plan future treatment and studies.